Non-alcoholic beverages: A foundational assessment of their potential utility in reducing alcohol use

Abstract. Non-alcoholic beverages that seek to mimic alcohol (e.g., non-alcoholic beers, non-alcoholic wines,
non-alcoholic liquor, and “mocktails”) are rapidly expanding in popularity and availability, with a 15-30% annual
increase in U.S. sales since 2018. Non-alcoholic beverages are most commonly consumed by people who also
consume alcohol and consumers often report using these drinks to try to reduce their alcohol use. Research on
the relation between non-alcoholic beverage use and alcohol use is needed to inform consumers, clinical
providers, and public health professionals about whether non-alcoholic beverages help people to reduce alcohol
use (by serving as a substitute) or paradoxically stimulate it (through cue-induced craving). Through the
proposed K99/R00 Award, Dr. Bowdring will examine the potential utility vs. harm of non-alcoholic beverages.
Ecological momentary assessments (EMA; measures captured in real-time with prompts sent via smartphone)
will be used to sensitively test associations between non-alcoholic beverage use and alcohol use among people
with alcohol use disorders (AUD) and social drinkers. Aim 1 (K99): Estimate the relation between non-alcoholic
beverage use and alcohol use among people with AUD. Participants will be n=102 U.S. adults (ages 21-89) who
meet criteria for AUD and regularly consume non-alcoholic beverages. They will complete survey assessments
of non-alcoholic beverage use and alcohol cravings, as well as alcohol use measured via portable breathalyzers,
multiple times per day across multiple weeks. This study will inform methodological decisions for the R00 study.
Aim 2 (R00): Estimate differences in the relation between non-alcoholic beverage use and alcohol use between
people with AUD and social drinkers. With a larger sample size to support power in testing differences between
two distinct subgroups, the R00 EMA study (n=220) will replicate and build on the K99 study by also recruiting
social drinkers in addition to people with AUD. Exploratory Aim 3 (K99+R00): Model the relation between alcohol
craving, non-alcoholic beverage use, and alcohol use. In both the K99 and R00 study, the role of alcohol craving
in the relation between non-alcoholic beverage use and alcohol use will be explored, offering novel insight into
a potential theoretically-informed mechanism. Dr. Bowdring has prior training in lab-based alcohol research with
social drinkers and clinical experience as a licensed psychologist working with individuals with AUD. This
K99/R00 Award will enable Dr. Bowdring to gain training in: a) best practices for involving people with AUD in
research; (b) EMA methods for alcohol research; (c) strategies for leveraging research findings to inform clinical
practice and public health policy; and (d) transitioning to research independence. Mentorship will be provided by
experts in the fields of clinical research (Prochaska), EMA in alcohol studies (McCarthy, Fairbairn, Trull,
Boothroyd), and addiction prevention and intervention strategies (Humphreys). This K99/R00 Award will propel
Dr. Bowdring to launch an independent research career, dedicated to supporting NIAAA’s goals of identifying
behavioral causes of alcohol use and of preventing and reducing alcohol misuse.

Public health relevance
Narrative. While alcohol misuse remains a leading cause of preventable death and disability, non-alcoholic beverages that seek to mimic alcohol (e.g., non-alcoholic beers, non-alcoholic wines, non-alcoholic liquor, and “mocktails”) are drastically increasing in popularity, especially among people who consume alcohol. This project will examine whether non-alcoholic beverage consumption helps to reduce alcohol use or paradoxically stimulate it. Clarifying the potential utility of non-alcoholic beverages and whether their effects differ based on alcohol use history will ultimately inform clinical recommendations for people with alcohol use disorder and public health messaging at large.